Administrative Core

PROJECT SUMMARY (Administrative Core: Ding, Maier, Ramírez-Andreotta)
The University of Arizona Superfund Research Center (UA SRC) Administrative Core is the “glue” that holds the
many parts of our Center together making the “whole” greater than the sum of the individual Research Projects
and Cores. The Administrative Core integrates the many components of our Center to meet the needs of the
overall NIEHS Superfund Research Program, our stakeholders, and our community. The Administrative Core
encompasses both the management aspects as well as the creative development of our Center. The
management component includes the responsibilities for the supervision, direction, planning, and coordination
of the UA SRC, as well as communication with stakeholders and financial accountability. The development
component involves seeking innovative ways to increase the impact of our Center including building partnerships
within the University of Arizona, with our sister SRCs, and with our partners (NIEHS, Environmental Protection
Agency, Agency for Toxic Substances and Disease Registry, State agencies, communities, and the mining
industry). The overall goal of our Center is to overall goal is to construct a mechanistic model of how chronic
exposure to dust that is co-contaminated with metal(loid)s and fungal spores contributes to the development of
nonmalignant lung disease and build risk assessment tools to predict exposures and associated health outcomes
and inform public health prevention and interventions with communities neighboring mine waste sites. Our
Administrative Core objectives are to: (1) plan, manage and coordinate the research projects and support cores
to ensure they attain the proposed shared research, training, and translational objectives; (2) promote the
exchange of scientific information at all levels through interaction with NIEHS and stakeholders and the
translation of our research products to risk assessment, intervention, education, and hazardous waste site
management and remediation; (3) creatively leverage our Center to expand our research base and our ability to
test and transfer new exposure assessment, intervention, and remediation technologies; and (4) facilitate the
UA SRC to serve as a global resource for human and environmental health issues associated with metal mining
in arid regions in the U.S. and around the world.

Public health relevance
PROJECT NARRATIVE (Administrative Core: Ding, Maier, Ramírez-Andreotta) The primary tasks of the University of Arizona Superfund Research Center Administrative Core include guiding our Center as a whole to define the human and environmental health risks associated with metal mining in arid environments. The Administrative Core also leads our Center in the development of innovative, cost-effective, long-term, evidence-based solutions that will effect change in the current mining industry practices and ensure the protection of human health and the environment. The final task of the Administrative Core is to coordinate the communication of Center findings to our partners including NIEHS, our sister Superfund Centers, Federal, State, and Tribal regulatory agencies, the mining industry, and affected communities.